Elucidating Mechanisms of Therapy-Resistance to Interferon-alfa in Myeloproliferative Neoplasm Stem Cells - Diversity Supplement

PROJECT SUMMARY
Recombinant interferon-alpha (IFN) remains a highly effective therapy for patients with myeloproliferative
neoplasms (MPN). We recently identified that patients with CALR-mutated MPN frequently exhibit normalization
of blood counts (i.e. clinical response), but often do not exhibit a decrease in tumor burden (i.e. molecular
response), providing an informative model to decipher the mechanisms of therapy-resistance to IFN.
Interrogating the molecular impact of IFN on human MPN stem cells may reveal critical insights into mechanisms
of therapy-resistance. Thus, we applied our innovative Genotyping of Transcriptomes (GoT) platform – that
captures the mutation status and single-cell whole transcriptomes (scRNA-seq) within the same cells – CD34+
cells from serial bone marrow (BM) aspirates from patients with CALR-mutated MPN treated with IFN. Strikingly,
we observed that IFN caused major shifts in the differentiation landscapes, distinctly in the mutated and wildtype
progenitors: IFN exposure on wildtype cells resulted in a large expansion of lymphoid progenitors, while the
mutated cells, in contrast, displayed an expansion of the granulo-monocytic (GM) progenitors (with a less striking
expansion of the lymphoid compartment). Our preliminary data indicate that (1) the GM differentiation bias of
CALR-mutated stem cells may underlie therapy-resistance, and that (2) the CALR-mutation induced UPR may
prime the mutated stem cells toward the GM lineage and play a role in therapy-resistance. To interrogate these
hypotheses, we will determine the transcription factor (TF) networks that govern the IFN-induced differentiation
shifts by applying a novel single-cell multi-omics platform that captures RNA-seq, chromatin accessibility and
somatic genotyping within the same thousands of single cells (GoT-ATAC) to the same IFN-treated cohort (Aim
1a), and by targeting these TF networks in mouse models (Aim 1b). We will define the role of UPR in therapy-
resistance in treated CALR-mutated cells through GoT-ATAC and chromatin binding assays (Aim 2a) and by
assessing perturbations to the UPR pathways in mouse models (Aim 2b). Finally, we will determine the impact
of co-mutations in DNMT3A or ASXL1 in therapy-resistance to IFN in CALR-mutated MPN via application of
single-cell multi-omics platforms to clinical samples (Aim 3a) and interrogation of IFN effects on novel mouse
models with double mutations (Aim 3b). The project is centered on a conceptually innovative framework in which
we superimpose neoplastic and normal hematopoietic development within the same individuals to define how
therapy reshapes differentiation topographies, as a function of mutation status and cell identity. This conceptual
innovation is enabled by technical innovations in single-cell multi-omics platforms applied to compelling clinical
cohorts, coupled with functional assessments in novel mouse models. These studies have the potential to
uncover new insights into the mechanisms of molecular resistance to IFN in MPN, resulting in novel therapeutic
approaches.

Public health relevance
PROJECT NARRATIVE Blood disorders that exhibit overproduction of blood components develop upon the acquisition of genetic mutations in genes such as CALR and result in disease states called myeloproliferative neoplasms (MPN). A major gap in our understanding of treating patients with MPN is the patient-to-patient variable outcome, including therapy-resistance to treatments such as interferon-alfa. Here, by applying novel tools that can sequence many genes in individual cells (`single-cell sequencing') on patient samples and mouse models, we seek to uncover the mechanisms of therapy-resistance.